Flaxseed effects on gut microbial metabolism and circulating inflammation-related metabolic profiles in African American and non-Hispanic white women

Gut microbial dysbiosis has been associated with alterations in production of immune and inflammatory cytokines and other circulating metabolites contributing to inflammation. Gut microbial composition and function are amenable to modification by diet. Flaxseed (FS), a whole food commonly consumed as a dietary adjuvant for several purported health effects, is a rich source of the polyphenolic lignans. Structurally similar to endogenous estrogens, lignans have been most widely studied for phytoestrogen effects; however, anti- inflammatory, immunomodulatory, and antioxidant effects have also been reported, primarily in animal and cell models. Importantly, to become physiologically available to humans, plant lignans require metabolism to enterolignans by a consortium of gut microbial community members, but not all individuals are enterolactone producers. Plant lignans are converted by the gut bacteria to the primary circulating enterolignan enterolactone (ENL) which can be measured in most body fluids. ENL has been inversely associated with several inflammation-related chronic diseases and, as a bacterial metabolite, has significant potential to impact health. Using existing data and specimens from a completed flaxseed intervention study in healthy, postmenopausal African American (AA) and non-Hispanic White (NHW) women that investigated the impact of the intervention on gut microbial communities, lignan metabolism, and steroid hormone metabolism, we will accomplish the following Aims: 1) In the overall study sample, determine associations between gut microbial community profiles, circulating metabolic profiles, and circulating inflammation-related cytokines for women who are high vs low ENL producers; 2) In a subset of women (n=80; 40 high producers [20 AA, 20 NHW], 40 low producers [20 AA, 20 NHW]), utilize metatranscriptomics to a) characterize the impact of the FS intervention on pre- and postintervention microbial gene expression, b) determine associations between microbial gene expression and circulating metabolites and inflammation-related cytokines, and c) how these associations differ by producer status and race; and 3) In the subset of women in Aim 2, utilize fecal metabolomics to characterize microbial metabolic profiles pre- and post-intervention, and determine associations with microbial gene expression (metatranscriptomics), circulating metabolites, and inflammation- related cytokines. We hypothesize that the FS intervention will modify microbial gene expression and metabolic pathways related to chronic low grade inflammation and these pathways will differ by producer status and for AA and NHW women. The proposed study offers a unique opportunity to characterize changes in microbial function and subsequent modification of circulating metabolic profiles related to chronic low grade inflammation in a generous sample of AA and NHW white women. Given the higher incidence of inflammation related chronic disease in AA, this study will contribute significantly to our understanding of the role of the microbiome in inflammatory metabolic processes.

Public health relevance
The proposed research has potential to identify biologic signatures by which dietary components could be leveraged into interventions or treatments to reduce chronic inflammation and immune phenotypes associated with chronic disease.